Modulation of Mitofusin Activity to Treat Heart Disease

Mitochondrial “connectivity” and mitochondrial-endoplasmic/sarcoplasmic reticulum (ER/SR) “proximity” each
potentiate mitochondrial-mediated metabolism and necrosis through a variety of mechanisms. Mitofusins (MFN)
1 and 2 are large GTPases that play critical roles in mitochondrial connectivity and mitochondrial-ER/SR
proximity. MFN1 and MFN2 reside in the outer mitochondrial membrane where they mediate mitochondrial
fusion. MFN2, but not MFN1, also resides in the ER/SR membrane, where it tethers ER/SR to mitochondria
through interactions with mitochondrial-localized MFN1 or MFN2. Deletion of MFN1 or MFN2 reduces myocardial
infarct (MI) size during ischemia/reperfusion (I/R). Conversely, MFN1 and MFN2 overexpression augment
metabolism. Given this information, therapeutic inhibition of MFNs would be expected to reduce infarct size
during MI, while therapeutic activation of MFNs might attenuate heart failure (HF) by augmenting metabolism.
The challenge has been to find a means to manipulate the activities of endogenous MFNs. In collaboration with
others, we created the first peptides and small molecules that modulate conformations of MFN1 and MFN2 and
delineated the underlying structural basis for these effects. We reported previously that MFN activators increase,
while MFN inhibitors decrease, mitochondrial fusion. These are direct effects that require binding of these agents
to either MFN1 or MFN2. We present here new data showing that MFN activators increase, while MFN inhibitors
decrease, mitochondrial-ER/SR proximity and Ca2+ transfer to mitochondria. Moreover, we observed that MFN
activators exacerbate infarct size during myocardial I/R, while MFN inhibitors reduce infarct size in both heart
and brain I/R models. Interestingly, these effects of the activators are dependent on MFN2, but not MFN1,
suggesting the importance of mitochondrial-ER/SR proximity but not excluding the possibility that MFN2-
dependent changes in mitochondrial connectivity and shape also contribute. Additionally, MFN activators
promote cardiomyocyte metabolism. The goals of this project are to understand the mechanisms by which MFN
modulators impact cardiomyocyte death and metabolism and to test whether these agents might provide novel
therapeutic strategies for MI and HF. We propose: 1. To correlate changes in MFN activation/inhibition with
mitochondrial connectivity, mitochondrial-ER/SR proximity, Ca2+ transfer, cell death, and metabolism in adult
cardiomyocytes. 2. To delineate the individual contributions of mitochondrial connectivity and mitochondrial-
ER/SR proximity to cell death and metabolism in cardiomyocytes in vivo. 3. To assess whether mitofusin
modulators provide novel therapeutic strategies for MI and HF. This project breaks new ground in defining the
mechanisms by which MFN modulators impact cardiomyocyte death and metabolism and whether MFNs provide
an actionable target for novel therapies directed against MI and HF.

Public health relevance
Mitochondria and endoplasmic/sarcoplasmic reticula are “organelles” (structures) in cells that regulate cell metabolism and cell death. We have devised molecules that regulate proteins called mitofusins to alter the physical and functional relationships among these organelles and, thereby, influence cell death and metabolism. We propose in this project to (a) delineate mechanisms by which mitofusin modulators impact heart muscle cell metabolism and cell death and (b) test whether mitofusin modulators provide new therapeutic strategies for myocardial infarction (“heart attack”) and heart failure, the two most common and lethal heart diseases.